Assessing Cognitive Overload in People with Multiple Sclerosis

PROJECT SUMMARY
Cognitive complaints are common in people with multiple sclerosis (PwMS), and cognitive deficits significantly
impact their quality of life and employability. These complaints are observed across various stages of the disease,
including early in the disease process when standard neurocognitive tests may yield "normal" results. A
commonly reported cognitive concern is the experience of “cognitive overload”, defined as a situation where the
cognitive load imposed by a task surpasses an individual’s cognitive processing capacity, leading to reduced
task performance and negative affective experience. To better understand and quantify cognitive overload, the
field needs novel tools that can capture subtle changes in affect and cognition, which may be more reflective of
early cognitive impairment and better replicate real-world cognitive challenges. For example, prior studies have
shown that PwMS experience worsened cognitive performance during dual-task walking and virtual reality (VR)
games under increased environmental stressors, which better align with their subjective cognitive difficulties.
This study posits that cognitive overload in PwMS results in a state of dysregulated affective reactivity and acts
as a harbinger of subclinical cognitive change. The overarching goals of this study involve characterizing
cognitive overload in PwMS using a multimodal approach. This approach includes cognitive testing, digital facial
movement analysis, patient-reported outcomes (mood, fatigue, cognition), and physiological measurements
while inducing overload through cognitive testing tasks with added interference conditions. In Aim 2, we will
assess the degree of overwhelm under interference conditions using established tools and novel biomarkers.
Participants will undergo cognitive testing with added auditory and dual-task interference conditions to increase
cognitive load. Novel physiological and facial expressivity metrics will be used to capture the experience of
cognitive overload. In Aim 2, we will leverage the Brainwalk study to investigate if degree of cognitive overload
in dual-task performance predicts cognitive scores (processing speed) at 2 year follow up. In Aim 3, we will
explore the relationship between objective and subjective measures of cognitive load by correlating established
subjective measures not previously used in MS to established objective measures of cognitive interference cost;
additionally we will use structural qualitative interviews to evaluate for novel aspects of subjective overload in
this population to inform survey improvement. This research is vital for improving symptom recognition related
to cognitive impairment in PwMS and enhancing systematic research in this domain. The significance of this
work lies in its potential to provide valuable insights into the experiences of PwMS with cognitive concerns and
to develop new tools for clinical trials aimed at stabilizing cognitive impairment progression in multiple sclerosis
and other neurodegenerative diseases.

Public health relevance
RESEARCH NARRATIVE This study addresses specifically the concept of "cognitive overload" in people with multiple sclerosis (MS), where cognitive load imposed by a task surpasses an individual’s cognitive processing capacity, leading to reduced task performance and negative affective experience, even if standard neurocognitive tests appear normal. We hypothesize that cognitive overload in people with MS (PwMS) results in a state of dysregulated affective reactivity and acts as a harbinger of subclinical cognitive change. Through a multimodal approach, the study aims to generate and assess cognitive overload under interference conditions, determine if overload predicts future cognitive decline, and explore the relationship between subjective and objective load assessments to better understand and identify cognitive impairment in MS, potentially leading to the generation of improved tools to identify and monitor cognition in treatment strategies for people with MS.